Data Management and Analysis Core (DMAC)

Abstract
The Data Management and Analysis Core (DMAC) works closely with all Center components to provide high
quality data management and analysis in support of Center research goals of exploring developmental and later-
life health effects of early life exposures to PAH’s and metals. The DMAC will support management and
integration of data assets across the Center through development and deployment of a Center-wide Data Asset
Inventory and specific to each project (and cores conducting data collection) a comprehensive Data Management
Plan, Data Quality Plan, and Statistical Analysis Plan. DMAC will provide state of the art data science and
statistical analysis support to projects and cores as needed. DMAC will develop ontology-backed search tools to
facilitate within-Center exploration of project findings and will develop and deploy innovative data visualization
and search tools to help researchers (within the Center and beyond) explore Center data assets and potential
connections with other relevant research.

Public health relevance
Project Narrative The Data Management and Analysis Core (DMAC) works closely with all Center components to provide high quality data management and analysis in support of Center research goals of exploring developmental and later- life health effects of early life exposures to PAH’s and metals. The DMAC will work with projects and cores to make data FAIR, to implement reproducible research best practices, and to develop and deploy innovative tools to help external researchers and citizen scientists explore Center data and findings.